CAU G-RISE

PROJECT SUMMARY/ABSTRACT
The biomedical research training program, CAU G-RISE Program, will build upon our current graduate
program and implement a formal training program in biomedical sciences. A major strength of the proposed
program is our track record in training underrepresented students, and our broad expertise and interests in
biomedicine giving our students a broad offering of approaches to conduct research in biomedicine. Our
primary goal is to competitively train underrepresented students in biomedical sciences, and build a
competitive and inclusive training environment that fosters a positive training experience, and in the long-term,
retention in biomedical sciences. We will require graduate student participation in academic and career
development activities that will enhance their competitive fit for the biomedical workforce. We will continue to
provide high quality research experiences, and enhance their research acumen with core facility training and
R- Suite certification. We will provide support activities to improve scientific writing skills and expect a
significant increase in applications for predoctoral fellowships. We will also strengthen peer-trainee
relationships with learning communities. To ensure a supportive training environment, our mentors will
regularly undergo training in mentorship skills which will create a community of unified expectations for student
outcomes. In the end, we expect predoctoral trainees to transition to biomedical careers and make life-long
contributions to the field. Our current training environment, along with CAU G-RISE, will produce a robust and
competitive program that will produce competitive scientists who are traditionally underrepresented in the field.

Public health relevance
PROJECT NARRATIVE The biomedical training program, CAU G-RISE, is focused on training highly motivated predoctoral students in biomedical sciences with special emphasis on training activities to support success. Trainees will participated in activities that fosters development of skillsets that are transferable to the diverse career opportunities in the biomedical workforce. The proposed program will mentor trainees and faculty to achieve scientific goals of significance, and make long-term contributions to the biomedical research enterprise.